Inter-organ signals regulating body size, physiology anddevelopmental timing

Inter-organ signals that regulate body size, physiology and developmental timing
Identifying and characterizing physiologic mechanisms that regulate organ
communication and function during development and adulthood is vital for understanding
how many important human health problems arise and intensify during our lifetimes.
This proposal outlines a research strategy to further characterize key signaling systems
that regulate critical and conserved physiological processes. These include determining
how a signaling network of three Drosophila Activin-like members of the TGF-beta
superfamily coordinately control fundamental aspects of brain, muscle, and fatbody
cellular function in response to environmental variables such as nutrition during
development to maintain physiologic homeostasis and how neuroendocrine mechanisms
regulate steroid production and release, also in response to various internal and external
cues, to properly time developmental maturation. We will use a wide variety of modern
biological investigative methods including genetic analysis, neuronal circuit and activity
mapping, biochemistry, optical/EM imaging, metabolomics, temporal and tissue specific
transcriptome characterization as well as chromatin immunoprecipitation experiments, to
answer these questions. Impact on human health: The successful completion of these
aims will provide novel insight into how an two very conserved inter-organ signaling
networks parse out specific, as well as combinatorial control, over various fundamental
cellular processes to produce a properly proportioned animal, that is optimized for
survival in its particular ecological niche. It is expected that this knowledge will provide
useful paradigms for understanding functional aspects of the more complex, but highly
related vertebrate TGF-beta and neuroendocrine signaling systems, and will afford novel
insights into molecular mechanisms that contribute to a number of human disorders
including obesity, metabolic syndrome, muscle wasting, pubertal disorders and ageing.

Public health relevance
The studies described in this proposal will functionally characterize two highly conserved inter-organ communication systems that are essential for ensuring proper control of body size and function during an organism’s development and interactions with its surroundings. Identifying and characterizing these mechanisms is central to understanding many fundamental issues that underlie significant human health problems including obesity, endocrine abnormalities, and developmental disorders.